Telomeres and Vascular Aging

The use of chronological age in clinical practice and in aging research is based on the premise that biological aging proceeds at an identical pace for all human beings. Such an approach overlooks the pnncipals of biological diversity. The central hypothesis of this project is that telomere length, as expressed in white blood cells, provides an account additional to chronological age, of variation in vascular aging among human beings. This hypothesis will be tested in the Offspring Study cohort of the Framingham Heart Study. The project will also seek through genome-wide search for genetic regions with large effects on telomere length. The specific aims of this project are: 1. To examine the relations between telomere length and indices of arterial aging in the previously phenotyped/genotyped Offspring Study cohort of the Framingham Heart Study. The indices of arterial aging include: brachial pulse pressure, central pulse pressure, augmentation index, and carotid-femoral, carotid-radial and carotid-brachial pulse wave velocities; 2. To assess heritability of telomere length and identify genetic loci that explain variation in telomere length. Results would lead to a better understanding of the heterogeneity of vascular aging, test the concept that telomere length may serve as an index of biological aging, and provide information on genetic determinants of telomere length in human beings.